EFFICACY OF HERPES SIMPLEX CANDIDATE VACCINE WITH MPL

The purpose of this medical research is to determine the safety and effectiveness of vaccine, Herpes Simplex Candidate Vaccine with Alum and MPL, in the prevention of herpes simplex type 2 infection in persons exposed to genital herpes infections.